Chicago Data-driven OUD Screening, Engagement, Treatment and Planning (C-DOSETaP) System

Project Summary/Abstract
In alignment with the HHS Overdose Prevention Strategy, this HEAL Data2Action Innovation Project
proposal addresses primary prevention, harm reduction, treatment of OUD, and recovery support using a
state-of-the-art data driven approach that will bring together elements of the University of Illinois
Hospital and Clinics (UI Health) and University of Illinois Chicago into a single, unified approach that is
capable of reducing mortality and morbidity from OUD on the westside of Chicago. We will deploy a
combination of machine learning (natural language processing of electronic health records data), state
reported prescription monitoring data, and patient reported measures to determine individual and group-
level OUD risk across the various UI Health care sites (Priority 2, Innovation Project). We will then use
this data at both the individual level (to facilitate clinical care) and at the community/system level (to
support resource allocation and planning).

Public health relevance
Project Narrative This project seeks to improve screening for opioid use disorder by using computerized screening combined with patient self-reported information. It is anticipated that this approach will improve care for patients, increase the number of people treated, and reduce injury and death due to opioids in Chicago.